TRAINING PROGRAM IN LUNG BIOLOGY AND DISEASE

Project Summary
This is a renewal application to fund lung-related research training at the University of Texas Southwestern
Medical Center, at the postdoctoral (MD, PhD) level. The proposal is born out of a collaborative effort between
the Pediatric and Adult divisions involved in lung research at this Institute, and is thus interdepartmental at its
core. Thirty-three experienced investigators and research mentors representing 13 different clinical and basic
science departments and centers form a solid, diverse training force. This funding cycle we have reorganized
our mentor groupings from a unidimensional track system into a tridimensional matrix that varies along disease
focus, translational level, and scientific competency. Trainees may access their primary and secondary mentors
through entry into an appropriate point in the matrix and be encouraged to develop along different axes. This
structure encourages cross-disciplinary and trans-departmental training, and creates a framework for
professional and scientific development. Trainees will receive a comprehensive field- and project-specific
didactic curriculum. Both clinical and basic science trainees will be guided by an individualized advisory
committee that has both basic and clinical science mentors, to broaden the trainee’s perspective and facilitate
bench to bedside thinking. Emphasis will be placed on maintenance of project focus, creative experimental
design, state of the art technology, and early career guidance. The strength of this program lies in the highly
collaborative Institutional environment, the unique interdepartmental leadership and training faculty of the
program, and the experienced and dedicated faculty serving as trainers.

Public health relevance
Project Narrative Lung diseases account for most of the leading causes of death in the United States and the rest of the world. Despite the need for further lung research targeted broadly at basic and clinical levels, there is a national shortage of clinically-directed scientists. This grant aims to fund a program to train postdoctoral scientists in both adult and pediatric research programs, to invest in the future of lung-related research.